Tritium Enrichment with Manganese Reagents

PROJECT SUMMARY/ABSTRACT
The goal of this project is to prepare tritium labeled compounds using the compound [Mn(CO)3(µ3-OH)]4 (1)
enriched with 3H atoms. Research in the Lacy group using 1 resulted in the discovery that d4-1 facilitates
hydrogen isotope exchange (HIE) with toluene under ambient conditions. This work continues this discovery
toward applications with tritium. The innovation in using 3H enriched 1 for labeling is that 1 is thermodynamically
stable and kinetically inert, except toward HIE, which is the desirable property for a labeling compound/catalyst.
Additionally, it is composed of only Mn iron and carbon monoxide and hydroxide ligands, it does not contain an
organic ligand. Purification of 1 from 3H-labeled material is very simple, which essentially takes advantage of the
low solubility of 1 or facile decomposition under UVA irradiation without solvent degradation. The irradiated
decomposition products are only manganese oxides, CO gas, and H2, all of which can be easily separated from
3H-labeled material. Aim 1 will demonstrate that this is possible. Aim 2 will explore and expand the substrate
scope. Namely, the original discovery by the Lacy group was with toluene. The proposed work will expand the
substrates to those including, but not limited to, substituted benzenes (e.g., chlorobenzene, bromobenzene,
iodobenzene, nitrobenzene, phenol, anisole, aniline, xylenes, mesitylene, hexamethylbenzene, pyridines,
furans, thiophenes, imidazoles, benzimidazoles, pyrrole, pyridines, pyrazoles, pyrazines, conjugated dienes) and
amino acids (e.g., phenylalanine, tryptophan, histidine). Additionally, pharmaceutical targets including, but not
limited to, Ibuprofen, Cimetidine, Pyrantel, Nitrofurantoin. A unique aspect 1 is that it can be used with neat
substrate. Aim 3 will explore fundamental chemical aspects of the labeling chemistry including the
thermochemistry, mechanism, and synthetic modifications that might be required to facilitate Aim 1 and/or Aim
2. The long-term goals are to (i) develop large scale preparation of 1 enriched with 3H, (ii) to do so using 3H2 gas
instead of tritium oxide, and to (iii) develop the technology with 1 for field use in pharmacology. The advantage
of using 3H2 gas is that it is much easier and safe to store and handle than tritium oxide. Pure tritium oxide is
corrosive and undergoes self-radiolysis, which is why it is usually manipulated in very low concentrations. Thus,
technologies that use 3H2 are more desirable than those that use tritium oxide, and efforts toward 1 leverage
and expand the advantages afforded from 3H2. The relevance to human health is that 3H-labeled compounds
are commonly used in pharmacology and the development of 1 in this area reduces the need for toxic and
expensive metal-based labeling strategies.

Public health relevance
Project Narrative Many strategies to incorporate tritium (3H) into molecules use toxic or expensive methods and often require the reagent tritium oxide, which is difficult to work with. This work provides a new strategy that relies on a unique labeling mechanism and manganese compound that can be prepared using more convenient 3H2. Our published data showing that the labeling strategy works for deuterium and toluene will be extended to include tritium and a wide range of small molecules including pharmaceutical compounds.